CORE--RESEARCH PHARMACIST

The Research Pharmacist Shared Resource coordinates and oversees all research related to the Department of Pharmacy. Specifically, this 0.5 FTE has primary responsibility for maintaining the inventory of investigational drugs; develops and presents educational programs for nursing, pharmacy, and the medical staff related to clinical research protocols; designs and implements Quality Improvement initiatives related to clinical research; acts as a liaison between the Department of Pharmacy and the Protocol Office; and serves on the IRB and the Scientific Review Committee.